Next Generation KUH Researchers (GENERATOR) Network Core

NETWORKING CORE – ABSTRACT
Our Networking Core (NC) will function synergistically with the Professional Development (PDC) and Training
Cores (TC) to foster a culture of community and collaboration among trainees. Our leadership team has
worked to ensure that networking mechanisms, including those led by trainees, underlie and are infused into
the curricula of both Cores. Our NC will create infrastructure to support a bridge that joins trainees of this
Program with others in the KUH research space, including the Collaborating for the Advancement of
Interdisciplinary Research in Benign Urology (CAIRIBU) Community, a multi-institutional, multi-center
collaborative of Urology O’Brien Centers, P20 Centers, and K12 Career Development Programs directed by
Dr. Penniston (GENERATOR NC co-director) (Table N1). Our GENERATOR Program is unique since both
institutions have currently-funded CAIRIBU Centers and Programs. Collectively, these Centers and
Programs afford this NC a unique ability to directly leverage existing outreach programs and promote new
interactions and research opportunities among GENERATOR Program urology trainees. To serve all of our
KUH trainees we will also build relationships with leaders of the Cooperative Centers of Excellence in
Hematology (CCEH)1 and its central coordinating center (University Utah) and the National Coordinating
Center for the George M. O'Brien Kidney National Resource Centers (University of Alabama at
Birmingham).
To accomplish these goals our GENERATOR Networking Core Specific Aims are:
AIM 1. Complement the training of 21st century collaboration and communication skills with practicum
environments. Our primary objective is to develop opportunities for trainees to operationalize,
practice, and sharpen the collaboration and communication skills learned in our Program.
AIM 2. Encourage and foster a virtual trainee-led “community of practice” and other forums that afford
trainees an unsupervised forum to relate to one another and interact. Our primary objective is to
provide a forum to enhance trainees’ relatedness and communication.
AIM 3. Share metrics of successes, best practices, and opportunities for improvement. Our primary
objective is to comprehensively evaluate all elements and outcomes of our initiatives.

Public health relevance
The GENERATOR Networking Core will work together with the Professional Development and Training Cores to foster an environment of community and collaboration among trainees. Our leadership team has worked to ensure that networking mechanisms, including those led by trainees, underlie and are infused into the curricula of both Cores. Our Networking Core will also create the infrastructure to support a bridge that joins trainees of this Program with others in the KUH research space